Biostatistics Shared Resource

BIOSTATISTICS SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The Biostatistics Shared Resource (BSR), as a functional unit of the Yale Center for Analytical Sciences
(YCAS), was established in 1995 to provide comprehensive, effective, and timely biostatistical support to Yale
Cancer Center (YCC) and other YSM investigators. BSR has a highly experienced and interactive team of
biostatisticians who work collaboratively with basic, clinical, translational, and population science researchers
to advance the frontiers of cancer medicine and public health. The BSR faculty also offer workshops, office
consultations, lectures, seminars, Grand Rounds, and courses on study design, analysis methods, and
software implementation to medical students, fellows, research staff, and faculty. To provide more tailored
cancer biostatistical support and to further strengthen the area of bioinformatics, Dr. Shuangge Ma, was
appointed as the Director of BSR in 2016.
During our most recent funding period, we have witnessed a significant increase in the demand for
biostatistical and bioinformatics support. The growth has been driven by the strengthening of specific programs
(such as Developmental Therapeutics – DT) as well as cancer research overall, by multi-investigator large
projects such as the SPOREs as well as R01-type projects. Other notable accomplishments include
strengthened expertise in bioinformatics and clinical trials, added expertise in biomedical big data, and
additional infrastructure building. In the next project period, the primary goal of the BSR is to further strengthen
our biostatistical and bioinformatics support to YCC investigators and projects.
The Specific Aims of BSR are to: (1) Provide robust, comprehensive, and timely biostatistical and
bioinformatics support to all YCC investigators; (2) Develop special emphasis on the areas of bioinformatics,
clinical trials, and multi-investigator studies (SPOREs, center grants, etc.); (3) Reinforce strong ties with YCC
programs, other shared resources, YSPH, YSM, and cancer biostatisticians/programs nationwide; (4)
Implement state-of-the-art methods, and develop new methods and software as needed to support cancer
research; (5) Continue providing training in standard statistical practice as well as advanced analytic
techniques to medical students, fellows, research staff, and faculty, via seminars, Grand Rounds, lectures, and
courses.
Over time, the BSR has been established as a critical component of YCC, and it will play an increasingly
important role in the coming funding period.
!